SIRT1 Signaling in Injurious Chondrocyte Mechaotransduction

PROJECT SUMMARY
High-energy trauma to an articular joint delivers a mechanical overload to cartilage tissue and causes an
injury response in chondrocytes that frequently leads to post-traumatic osteoarthritis (PTOA). Because cartilage
has limited intrinsic repair capabilities, there is an unmet clinical need for new therapies to treat cartilage injury
and inhibit progression of PTOA. The mechanosensitive signaling pathways that mediate the injury response of
chondrocytes to mechanical overloads are not well understood. Filling these gaps in knowledge may provide
new therapeutic targets following joint injury that prevent or delay the development of PTOA.
Our preliminary data identify Sirtuin1 (SIRT1), an NAD+-dependent protein deacetylase, as a newly-
discovered mechanosensitive signaling molecule in chondrocytes’ response to injurious overload. SIRT1 activity
decreased in bovine cartilage explants within 5 minutes of a sublethal impact overload, and remained
suppressed for at least 24 hours. Preliminary experimental results also suggest the likely pathway that regulates
SIRT1 deactivation. Importantly, pharmacological activation of SIRT1 completely rescued the acute injury
response in the cartilage explants. The first objective of this study is to define upstream signaling pathways that
regulate SIRT1 deactivation in the injurious mechanoresponse of chondrocytes. This will be accomplished in
Aim 1 using pharmacological inhibitors and a CRISPR/Cas9 strategy. Additionally, the major mechanism for
SIRT1 to regulate cellular processes is to deacetylate proteins. Therefore, a second objective is to analyze the
acetylome to determine the downstream substrates of SIRT1 in mechanically loaded chondrocytes, and to clarify
the role of these deacetylation targets in the chondrocyte injury response and/or chondrocyte behavior. This
objective will be met in Aim 2 with a proteomics approach to identify deacetylation substrates with mechanical
overload. The role of at least one of these targets in the injury response to mechanical overload and/or cartilage
health will be evaluated. Finally, whether SIRT1 regulation maintains cartilage homeostasis following cartilage
injury will be assessed in Aim 3.
The proposed study breaks new ground, as it investigates the mechanically induced enzymatic
deactivation of SIRT1, which had not previously been recognized as mechanosensitive in chondrocytes, in the
impact injury response in cartilage. As sirtuins were initially recognized as pivotal regulators of aging and
longevity, successful completion of the proposed work may provide a molecular link between injury-induced and
age-related osteoarthritis, transforming our understanding of the disease. Furthermore, understanding the
signaling pathways that are upstream and downstream of SIRT1 enzyme deactivation will identify new molecular
events in the injury response of chondrocytes and may reveal previously undiscovered regulators of cartilage
health. These results are expected to form the basis for new approaches to treat cartilage injury and novel
therapeutic targets to induce articular cartilage repair.

Public health relevance
PROJECT NARRATIVE A mechanical overload to cartilage induces an injury that often leads to post-traumatic osteoarthritis, but the signaling pathways that mediate the progression from cartilage injury to disease are not well understood. The overall objective of the project is to evaluate the role of SIRT1 signaling, a molecule that was newly discovered to be mechanically regulated following cartilage injury, in the cellular response to mechanical overload. If successful, results could indicate new strategies for improving cartilage health and preventing the progression of cartilage degeneration following joint trauma.